COMPREHENSIVE CANCER CENTER PROGRAM AT FOX CHASE

The aim of this proposal is to continue the supportive financial base of our programs in cancer research. This includes the development of some existing programs, as well as the addition of new programs in both laboratory and clinical cancer research.